Network of the National Library of Medicine Evaluation Center

The Network of the National Library of Medicine Evaluation Center (NEC) will develop and enhance best-practice evaluation strategies and resources for the benefit of the Network of the National Library of Medicine (NNLM). The NEC will collaborate with NNLM and Regional Medical Libraries (RMLs), Offices, and Centers to develop standardized processes and robust integrated visualization and reporting tools and data for evaluation and communication of program activities, outcomes, and impact. We will assess the efficacy and outcomes of NNLM activities, services, and resources. Collaboration and capacity building are made a priority through workforce and network development activities and resources directed to the National Library of Medicine (NLM), Regional Medical Libraries (RMLs), Offices, and Centers (ROCs), and network members. We will work with the NLM User Engagement Program (UEP) and the NNLM Steering Committee (SC) to align this proposed work with the NLM Strategic Plan and with emerging strategic priorities during the funding period. Through this opportunity, we will support and advance NNLM’s mission “to advance the progress of medicine and improve the public's health by providing U.S. researchers, health professionals, public health workforce, educators, and the public with equal access to biomedical and health information resources and data.”

Public health relevance
The Network of the National Library of Medicine Evaluation Center (NEC) will provide the Network of the National Library of Medicine (NNLM) with data-driven resources to support evaluation, continuous improvement, and communication of impact of programs and activities. This work will be made openly available and support the use of evaluation to support and advance NNLM’s mission.